Optimizing prognostic and predictive algorithms using residual disease (RD) genomic biomarkers in HER2+ and TNBC

Abstract
HER2-positive (HER2+) and triple negative breast cancer (TNBC) are the most aggressive clinical breast
cancer subtypes and share similar treatment approaches and unmet needs. Both are treated with either anti-
HER2 drugs (for HER2+), or immunotherapy (for TNBC), added to polychemotherapy prior to surgery, called
“neoadjuvant” therapy. Residual disease (RD) at surgery is seen in 45% of HER2+ and 35% of TNBC and
carries a significantly poorer prognosis. For this reason, both HER2+ and TNBC receive additional therapy
postoperatively ("adjuvantly"), namely an anti-HER2 antibody-drug conjugate (ADC) in HER2+, and additional
chemotherapy added to ongoing immunotherapy in TNBC. This approach has resulted in significantly improved
outcomes in both of these subtypes but is expensive, toxic, and overtreats many patients. We aim to better
understand the biology and heterogeneity of the residual disease setting, including prediction of response to
therapy and prognosis, in order to better tailor adjuvant therapy.
We and others have previously identified a common theme in neoadjuvantly treated HER2+ and TNBC in that
immune activation assessed by T cell and B cell gene expression in untreated tumors is a strong predictor of
complete response (pCR) to chemotherapy, HER2-targeting, and immunotherapy, resulting in improved
survival. However, we still lack biomarker information to tailor treatment in RD. We now propose to focus on
the unmet needs of patients with RD in both HER2+ (Aim 1) and TNBC (Aim 2) by integrating and analyzing
data from >2,500 women participating in clinical trials from each subset, by performing genomic analysis of RD
specimens and using these data to improve prognostication in the two clinical subsets. We will compare paired
untreated versus post-treatment RD tumors to identify how tumor and immune biology is changed in residual
disease. Importantly, we will determine if biomarkers assayed from RD specimens improves prognostication
and identification of those who may need, or not need, additional postoperative ADC (in HER2+) or
chemotherapy (in TNBC). We will use supervised learning to build multi-feature computational prognostic
models using RD specimens. We will examine the nature and role of residual disease tumor cells and the
microenvironment by single-cell spatial transcriptomics to further understand how the interaction between both
elements affects survival outcomes in patients with HER2+ and TNBC.

Public health relevance
Project Narrative We propose to comprehensively examine the role of tumor and microenvironmental factors determining outcome in patients with residual disease after neoadjuvant therapy in HER2- positive and triple negative nonmetastatic breast cancer. We will do this by integrating RNA sequencing and clinical features of over 1500 patients with HER2+ breast cancer, and over 1200 patients with triple negative breast cancer from multiple neoadjuvant clinical trials in order to: a) determine if pre-treatment or residual tumor biology is more prognostic, and b) develop prognostic algorithms for outcome in those with residual disease, including identification of those with good prognosis without additional postoperative adjuvant antibody-drug conjugates (for HER2-positive) or chemotherapy (for triple negative). Using spatial transcriptomics we will also examine B and T cell interactions with tumor cells in residual disease specimens.